Reducing Off-Target Accumulation of Chemotherapeutic Nanomedicines

The work described in this proposal investigates a novel approach to reduce drug accumulation in healthy
tissues and improve the efficacy of chemotherapy. More specifically, we take advantage of recent studies
demonstrating an innate immune response (epithelial tightening) that limits viral infection, and our preliminary
data show that this response can be exploited to reduce the accumulation of nanoparticles in healthy tissues.
The key molecule involved in signaling the tightening response is IFN-λ, and we have shown that this cytokine
is produced in response to the injection of virus-like particles (lipoplexes). Moreover, pretreatment with this
cytokine elicits tightening in healthy tissues without affecting delivery to the tumor. We propose that eliciting this
response will permit unimpeded delivery to tumors under conditions where deposition in healthy tissues is
significantly reduced. As a demonstration of these effects, tumor-bearing mice pre-treated with IFN-λ exhibited
reduced accumulation of liposomal doxorubicin (Doxil®) in healthy organs, reduced toxicity, and improved
survival. By characterizing the tightening response in terms of IFN-λ dose, route of administration, and timing
as well as its effects on organ and skin toxicity, our experiments will identify conditions that can be used to
minimize adverse effects of chemotherapy while enhancing drug accumulation in the tumor. Finally, we will
explore the potential of utilizing the reduced accumulation in healthy tissues to more aggressively dose
chemotherapy in two syngeneic mouse models for ovarian cancer and conduct immune profiling to assess
synergistic effects of IFN-ʎ with Doxil.

Public health relevance
Current therapy for cancer involves exposure to toxic drugs that accumulate in many tissues besides the tumor. The wide distribution of these drugs in the body causes toxicity in healthy tissues that limits the effectiveness of therapy. The proposed studies investigate a new mechanism of reducing the distribution of drugs to healthy tissues such that the adverse effects associated with chemotherapy can be greatly reduced.